Pseudo semiparametric inference for case control studies

DESCRIPTION (provided by applicant): The use of complex sampling, e.g. stratified multistage cluster sampling, in population based case-control studies is becoming more common. In addition to the cost- and time-effectiveness, the use of complex sample designs can also obtain representative samples from the study population and avoid the biased selection of controls and/or cases. To realize the full potential of these advances, however, there are at least two complexities introduced by the complex sampling, including 1) differential selection probabilities and 2) the intra-cluster correlations. As a result, the sample distribution can be different from the underlying population distribution from which the sample is selected. In this project, we will develop statistical methods accounting for the two complexities for the estimation of effects from genes, environmental factors and their interactions on the risk of complex diseases. Specifically, attracted by the efficiency advantage of the retrospective method, we will explore the assumptions of HWE and GE independence, and develop an efficient estimator suitable for the case-control study with a complex sample design. In practice, many case-control studies apply frequency matched designs, where controls are selected in numbers proportional to the number of cases within matching strata during the complex sampling. We will further incorporate the frequency-matching design into our proposed estimators. The proposed methods will be evaluated using simulations as well as two population-based case-control studies with complex sample designs. A unified software package will be developed.

Public health relevance
Project Narrative This project proposes innovative statistical methods for the analysis of data from population-based case-control studies when controls are sampled with a complex sample design. The results of this project will contribute to the understanding of the interplay of the genetic susceptibility and environmental risk factors, and provide an important resource for designing future population-based case-control studies. __SpecificAimsTextDelimiter__ Specific Aims Most common human diseases have a multi-factorial etiology involving a complex interplay of both genetic and environmental factors. Understanding the relation between genetic polymorphisms and environmental exposures can improve the statistical power to identify underlying risk factors and susceptibility genes, and provide better insight into pathway mechanisms for complex diseases. A widely accepted design strategy in the study of the roles of gene-environment (G-E) interactions in determining the risk of human diseases is the population-based case-control study. Recently, the use of complex sampling (e.g. stratified multistage cluster sampling) for the selection of controls in population-based case-control studies is becoming more common. In addition to the cost- and time-effectiveness, the use of proper complex sample designs can also obtain representative samples from the study population and avoid the biased selection of controls and/or cases. To realize the full potential of these advances, however, there are at least two complexities introduced by the complex sampling, including 1) differential selection probabilities and 2) the intracluster correlations. As a result, the sample distribution can be different from the underlying population distribution from which the sample is selected. In this project, we will develop, implement, and assess the performance of statistical methods for integrated analysis of the interactions between genetic and environmental factors from population-based case-control studies when cases and/or controls are sampled with a complex sample design. Specifically, we have two aims: I. Develop statistical methods for detecting associations of genetic, environmental factors and their interactions with human disease when cases and/or controls are selected with a complex sample design. In particular, we will focus on the following two sub-aims: a. Explore the efficiency gains under different covariate-distributional assumptions, including Hardy-Weinberg Equilibrium among genotype frequencies and G-E independence in the population. b. Extend the statistical methods proposed in the first sub-aim to resolve the complexity introduced by the frequency-matched study design where the controls are selected in numbers proportional to the number of cases within the matching strata. II. Evaluate the proposed statistical methods in the first specific aim using data from two studies: (1) a study on the risk of kidney cancer associated with growth, differentiation and apoptosis genes EGFR and CASP; and (2) a study on the risk of classical Kaposi Sarcoma associated with susceptibility genes CCR9 and TLR2, in relationship to various lifestyle, dietary, and chemical exposures.